The role of senescence in severe COVID-19

ABSTRACT
Preexisting obesity and non alcoholic steatohepatitis (NASH) are strongly associated with COVID-
19 cytokine storm and severe outcome. SARS-CoV-2 virions are present in the patient adipose
tissue and liver at low levels and it is not known if they play a major functional role in severe
COVID-19 pathology. The Raabe lab has derived for the first time organoids from livers of patients
with NASH and shown that they are senescent and exhibit a senescence associated secretory
phenotype (SASP) and thus model the known senescence of hepatocytes and other liver cells in
end stage NASH liver. Further, SARS-CoV-2 has been shown recently to induce senescence and
an SASP in infected lung cells that spreads through senescence associated secretion of
chemokines and cytokines including chemokine CXCL10, interferon IFN and cytokine TNF to
attract macrophages and activate them to a pro inflammatory state. The Raabe lab will study the
hypothesis that genetic or chemical removal of senescent cells in SARS-CoV-2 infected obesity
or NASH mouse models or in human adipose tissues derived cells and NASH patient liver derived
organoids will alleviate NASH related severe COVID-19 symptoms. In Aim 1 we will induce
obesity and NASH senescence in mouse models and infect these with SARS-CoV-2. Prior or
after infection we will remove senescence promoting factor p16 expressing cells either genetically
or chemically and then determine if this alleviates severe obesity or NASH COVID-19 symptoms.
In Aim 2 primary human lung cells will be infected with SARS-CoV-2 and the supernatant
containing the SASP and virus will be added to primary human adipocytes or NASH liver derived
organoid cultures. We will remove senescent cells chemically using established senolytics to
study if their removal alleviates inflammatory responses. Readout will be RNA-Seq, IHC and
ELISA to study the effect on senolytics on the SASP.

Public health relevance
NARRATIVE Preexisting cirrhotic liver disease is strongly associated with severe COVID-19 outcome, including long COVID and death. Recently strong evidence has emerged that senescence, a physiological state of cells that is characterized by cell cycle arrest and pro inflammatory responses, is a functional feature of both cirrhotic liver disease and also is directly induced by SARS-CoV-2 in infected cells. We aim at testing if specific removal of senescent cells will alleviate severe COVID-19 symptoms in SARS-CoV-2 infected mice with preexisting NASH, or in SARS-CoV-2 infected NASH patient liver- derived organoids.